UTRGV Diversity Center for Genome Research

PROJECT SUMMARY
The University of Texas Rio Grande Valley seeks to establish a Diversity Center for Genome Research that will
build UTRGV’s genomics research capacity by 1) expanding genomic research capabilities and discoveries in
two innovative research projects; and 2) enhancing the size and quality of the available genomics workforce.
Leveraging the exciting activities and resources available in the two highly innovative research projects, the
Center’s structure and approach are designed to expand the pool of diverse genomic scientists, clinician
scientists, and researchers at both the doctoral and technical staff levels who can perform cutting-edge
multidisciplinary genomics research. The Center’s Workforce Development Core includes efforts to develop the
pipeline of Hispanic pre-college students interested in careers in genetics and genomics so that workforce
development programs will expand and become self-sustaining in the future. The Center’s Community
Engagement Core is designed to improve genomic literacy in the predominantly Hispanic local population and
increase interest in participation in genomic studies. The research in the two multidisciplinary projects to be
supported by the Center is focused on diseases that are important health disparities for the local Mexican
American population, nonalcoholic fatty liver disease and major depressive disorder. The team science-focused
research will be meaningful to our trainees since the diseases under investigation disproportionately impact
Mexican American families. The research programs leverage state-of-the-art instrumentation to provide
outstanding training opportunities for faculty, students, postdocs, and residents. Cutting-edge technologies are
incorporated into the projects, maximizing the impact of training and research experiences. Techniques and
approaches used in the projects include bioinformatics, computational genomics, statistical genetics, molecular
genetics, genetic epidemiology, genomics, proteomics, exposomics, stem cell biology, novel statistical methods,
environmental chemistry, environmental epidemiology, neuroscience, imaging genomics, and medical
anthropology. The proposed research areas provide an outstanding range of training opportunities and are rich
with potential spin-off projects for junior faculty and senior faculty seeking to branch into genomics. Through the
activities of its Administrative Core, Workforce Development Core, Community Engagement Core, and Research
Projects, the proposed UTRGV Diversity Center for Genome Research will support cutting-edge genomic
research, capacity building, and training in genomics at one of the nation’s largest Hispanic-serving institutions.

Public health relevance
PROJECT NARRATIVE The University of Texas Rio Grande Valley seeks to establish a Diversity Center for Genome Research that will build genomics research capacity by 1) expanding genomic research capabilities and discoveries in two innovative research projects; and 2) enhancing the size and quality of the available genomics workforce. The Center will leverage the exciting activities and resources available in two highly innovative research projects, one focused on non-alcoholic fatty liver disease and one focused on major depressive disorder. The Center’s structure and approach are designed to expand the pool of diverse genomic scientists, clinician scientists, and researchers at both the doctoral and technical staff levels who can perform cutting-edge multidisciplinary genomics research.